Mechanism of action of uniquely human genes in the injury response

PROJECT SUMMARY/ABSTRACT
Multi-organ failure as a result of the systemic inflammatory response to injury (SIRS) is the leading cause
of late complications and death after severe trauma and burn injury. Despite decades of research,
therapeutics that limit the SIRS response following injury remains an unmet clinical need. Emerging
research points to the contribution of human-specific differences in our immune system that distinguish
the human injury response from that observed in other species. These species-specific differences may
explain why therapies that are widely successful in animal models used for preclinical research fail in
human clinical studies. Uniquely human genes (UHGs), with expression that frequently tracks to human
immune cells, may account for some of these differences in human SIRS after injury. The overarching
goal of my research program is to systematically define factors that distinguish the human immune
response from other species, characterize the contribution of UHGs to human SIRS, and understand how
these genes effect therapeutics that target anti-inflammatory signaling pathways. To this end, we have
recently discovered a novel role for the uniquely human CHRFAM7A gene that is a variant of the
conserved α7 nicotinic acetylcholine receptor (α7nAchR) that mediates cholinergic anti-inflammatory
signaling. In addition to decreasing the ability of therapeutics to target the α7nAchR, unexpectedly, we
have demonstrated that human CHRFAM7A expression functions in transgenic mouse mice to cause
increased monocyte mobilization to lung and decreased acute lung injury in a model of severe burn injury.
Our research focus in this MIRA proposal is to identify the function and mechanism of action of UHGs
that are highly expressed in monocytes/macrophages and relevant in the injury response. To
demonstrate the functional relevance of UHGs, we will use a combination of precision animal models,
genetic approaches in human induced pluripotent stem (iPS) cells, and clinical samples from trauma and
burn patients. In this research program, we propose to 1) test cell-specific UHG function in an animal
model of severe injury; 2) develop an iPS cell system for mechanistic studies in human macrophages; 3)
determine how UHGs alter the effect of therapeutics that target anti-inflammatory signaling pathways;
and 4) evaluate how relative UHG expression alters the inflammatory phenotype of monocytes from
injured patients. Understanding how UHGs make the human immune response to injury unique may allow
for the development of novel therapeutic interventions aimed at modulating SIRS and decreasing organ
dysfunction after severe trauma and burn.

Public health relevance
PROJECT NARRATIVE Acute lung injury as a result of the systemic inflammatory response (SIRS) is a common cause of complications in patients following severe injury. Unfortunately, therapeutics that limit SIRS after injury are lacking, with poor translation of therapeutics from animal models into patients in the clinical setting. Here, we will identify the function and mechanism of action of uniquely human genes that are highly expressed in monocytes/macrophages, define their contribution to human SIRS, and understand how these genes effect therapeutics that target anti-inflammatory signaling pathways.